Prevention Research Center of Michigan: Transforming the Built Environment to create Safe and Equitable Spaces for Physical Activity

The Prevention Research Center of Michigan (PRC/MI) builds on over 30 years of experience working with
academic, public health and community based partners to reduce health disparities and create safe, healthy
and equitable futures through high quality community-engaged prevention research. Our Center brings
together a multidisciplinary team of researchers and practitioners in public health, implementation science,
physical activity, and urban planning, to extend our work on the built environment and apply an implementation
science framework to study to effective and sustainable vacant land reuse programs for physical activity in
Flint, Michigan (Category 9). Built environment approaches to improve physical activity such as walking paths
and community green space, have an established evidence-base in the literature. Yet, in communities with
high rates of violence and historical inequitable resource allocations, these approaches may be challenging to
implement and sustain. Further, in legacy cities such as Flint Michigan, high rates of abandoned housing and
land has created a complex structural and policy context for this work. Neighborhood safety, community
engagement and space activation are critical components to ensuring the success of these initiatives. Although
researchers have established both direct and indirect links between vacant land reuse programs and physical
health, there are gaps in our understanding of strategies to ensure initiatives are accessible, feasible and
sustainable. We also need further research into barriers and facilitators to adoption and implementation in
priority community and neighborhood contexts. Notably, there is a critical need to ensure equitable
implementation when working with and within these communities to understand what resources, expertise or
facilitations are needed to succeed. In collaboration with our multi-sector community advisory board, including
two local health departments, we will conduct a Hybrid Type III Effectiveness-Implementation study to improve
use and sustainability of vacant land reuse as a mechanism for increasing physical activity of local residents in
Flint, Michigan. We will partner with local public health departments to translate and build capacity for the
public health workforce to engage in this work. We will disseminate our methods, translation products, and
findings to various audiences including state and local policy makers, researchers, practitioners and residents.
Using a CBPR approach, our Center will engage a broad-based community advisory board (CAB) to guide all
PRC/MI activities. We will evaluate the activities, outputs, and outcomes of the PRC/MI and apply this
information to improve center, research activities, and ensure equitable processes.

Public health relevance
The Prevention Research Center of Michigan (PRC/MI) builds on over 30 years of experience working with academic, public health and community based partners to reduce health disparities and create safe, healthy and equitable futures through high quality community-engaged prevention research. In collaboration with our multi-sector community advisory board, including two local health departments, we will use a Hybrid Type III Effectiveness-Implementation design to improve use and sustainability of vacant land reuse as a mechanism for increasing physical activity of local residents in Flint, Michigan. We will partner with local public health departments to translate and build capacity for public health workforce to engage in this work and disseminate our methods, translation products, and findings to various audiences including state and local policy makers, researchers, practitioners and residents.